Peer Approaches to Lupus Self-Management (PALS)

PROJECT SUMMARY/ABSTRACT
The goal of the proposed project is to test an innovative, manualized peer mentorship program for African
American women with systemic lupus erythematosus (SLE). The Peer Approaches to Lupus Self-
management (PALS) study is designed to provide modeling and reinforcement by peers (mentors) to other
African American women with SLE (mentees) to encourage them to engage in activities that promote disease
self-management. This study builds on three decades of work conducted in the field of arthritis self-
management but differs in that the intervention mode (peer mentoring), the disease (SLE), and the study
population (African Americans) are unstudied or understudied. Through a randomized, controlled design, we
will assess the efficacy and mechanism(s) of this intervention on self-management and health related quality of
life (HRQOL). This program has three specific aims. The first aim seeks to determine the efficacy of a peer
mentorship intervention in African American women with SLE on disease self-management and HRQOL. The
second aim is to determine the impact of a peer mentorship intervention on patient-reported and clinical
indicators of disease activity. The third aim is to determine the cost effectiveness of a peer mentorship
intervention on disease self-management, disease activity, and HRQOL, in African American women with SLE.
An exploratory aim will be to determine the role of mediators and moderators of a peer mentorship intervention
on disease activity and HRQOL outcomes in African American women with SLE, to include disease self-
management, depression, trust, and social support. The immediate goal of proposed work is to determine the
efficacy of the program in a randomized design. The long-term goal is to disseminate this potentially cost-
effective intervention in diverse clinical and community settings in an effort to improve disease outcomes in
African American women with SLE and reduce morbidity and mortality in this high risk group. This effort could
result in a model for other programs that aim to improve disease self-management, disease activity, and
HRQOL in African American women suffering from chronic illness.

Public health relevance
PROJECT NARRATIVE The peer mentoring approach is uniquely fitted to African Americans, and this intervention has the potential to lead to health improvements for African American women with SLE that have not been attainable with other interventions and serve as a sustainable solution to persistent disparities that has the potential to change care. This would significantly reduce disparities and have considerable public health impact.